The Stanford Clinical Center for the Chronic Pancreatitis Research Consortium (CPCRC)

Project Summary/Abstract
This application to renew participation in the renamed Chronic Pancreatitis Clinical Research
Consortium (CPCRC) (formerly called the Consortium for the Study of Chronic Pancreatitis, Diabetes
and Pancreas Cancer [CPDPC]), will enable the Stanford Clinical Center to continue its productive
recruitment and retention of patients into 2 clinical studies of the consortium – 1) Prospective
Evaluation of Chronic Pancreatitis for Epidemiologic and Translational Studies (PROCEED), and 2)
Pediatric Longitudinal Cohort Study of Chronic Pancreatitis [The International Study Group of
Pediatric Pancreatitis: In Search for a Cure (INSPPIRE2). Prospectively collected specimens from
these studies will be used to further examine the role of the immune system in recurrent acute
pancreatitis and chronic pancreatitis with clinically relevant outcomes. As part of the original
Consortium, the Stanford Clinical Center, has demonstrated capacity to effectively recruit and retain
patients into 2 primary studies of the CPCRC. We have successfully used prospectively collected
samples from the PROCEED cohort to demonstrate key immune signaling pathways to diagnose
chronic pancreatitis. In response to the research objectives of the CPCRC as outlined in this RFA, we
have formed a strong scientific team with broad complementary expertise in clinical adult and
pediatric pancreatitis, endocrinology, radiology, and immunology. In this renewal, we intend to validate
these findings and characterize predictive immune signatures of chronic pancreatitis and relevant
clinical outcomes with 3 proposed ancillary studies – one of which will use serially collected samples
over time for the same patient. We also propose a proof-of-concept immune-based clinical trial to
repurpose a commercially available FDA-approved IL-17 inhibitor to prevent progression of recurrent
acute pancreatitis to chronic pancreatitis.

Public health relevance
PROJECT NARRATIVE The Stanford Clinical Center will continue to lead and actively participate in the research objectives of the Chronic Pancreatitis Clinical Research Consortium (CPCRC) by recruiting into the 2 key clinical studies and adult and pediatric chronic pancreatitis. Collected specimens from these studies will be studied to develop and validate new immunological insights into how chronic pancreatitis progresses and its complications. These insights will inform new diagnostic tests and treatments.